Cortical connectivity during functional balance reactions in stroke survivors

Project Summary/Abstract This section has not changed since the original Award.

Public health relevance
Project Narrative This section has not changed since the original Award.